Genome-wide association studies of anxiety spectrum phenotypes: Furthering the PGC Anxiety Disorders Working Group

Anxiety disorders such as generalized anxiety disorder, panic disorder, and phobias are
highly prevalent in the population and carry a significant burden of distress and
impairment. Only a moderate proportion of patients with anxiety disorders respond
adequately to current treatment interventions, and anxiety disorders are relatively
understudied compared to other psychiatric syndromes. Exploring their genetic
determinants will help elucidate their causes and guide research for prevention and new
treatments. In our first funding period, we built the foundation for conducting sufficiently
powered genome-wide association study (GWAS) meta-analyses for the anxiety
disorders through the newly established Anxiety Disorders Working Group of the
Psychiatric Genetics Consortium (PGC-ANX). We assembled data from 36 European
ancestry cohorts totaling 122K composite ANX cases and 730K controls. We performed
case-control SNP- and gene-based analyses and identified genome-wide significant
associations in 58 independent SNPs and 91 genes, respectively. The purpose of this
current application is to expand the sample size, identify susceptibility loci for each
anxiety disorder, and extend those results beyond European ancestry individuals. We
will apply these results to refine the prediction of clinical risk for anxiety. This study will
provide new insights into genetic mechanisms underlying the development of anxiety
disorders.

Public health relevance
Anxiety disorders are quite common, chronic, and disabling. Both genetic factors and exposure to environmental stress contribute to their development. The identification of the genes that play a role in their development can provide new clues to their causes and new directions for prevention and treatment research.